ALLERGEN RESOURCE REFERENCE LABORATORY

Acqure, store, distribute, and provide a central, independent source of data for bulk and packaged allergens and/or immunologic and immunopharmacologic reagents produced by other commercial and/or non-commercial sources or contractors. Provide investigators as designated by the Project Officer, with a centralized facility for assay of a variety of relevant immunologic and immunopharmacologic parameters on clinical specimens, e.g., sera by well standardized methods. Analyze, compare, and develop standard reagents and methodologies for immunodiagnosis. Isolate allergens with relevant biological activity.